Pre-trial implementation study for ketamine in sickle cell disease

Specific Aim 1: Assess healthcare stakeholders' perceptions of barriers to and facilitators for a
RCT of early administration of sub-anesthetic ketamine infusion as a pain adjunct for VOEs
using the Consolidated Framework for Implementation Research (CFRIR) and Proctor's
taxonomy for implementation outcomes. To achieve this, we will: 1A: Conduct a cross-sectional
survey study of healthcare professionals within EPPIC-Net who provide care for people with
SCD and/or provide guidance for administration of ketamine within their hospital system (i.e.,
specialties including hematology, emergency medicine, anesthesiology, and hospitalist medicine)
to assess barriers to and facilitators for the proposed RCT 1B: Conduct semi-structured
interviews of 15-20 healthcare professionals to assess barriers to and facilitators for the proposed
RCT.

Public health relevance
PROJECT NARRATIVE Pain research experts have concluded that a national clinical research network is necessary to develop novel non-addictive treatments for pain. In this proposal, we leverage existing resources to propose an efficient and high-quality clinical trial Hub-spoke complex of academic medical centers with considerable experience in pain management clinical trials and biomarker validation. Our collection of spokes will provide maximum flexibility, ready to accommodate studies in any well characterized pain condition.